CT Flexible Funding Model - MFRPS Maintenance for Connecticut DCP

Project Summary/Abstract
Maintenance for ConnecƟcut’s Manufactured Food Regulatory Program Standards program. ConƟnued
funding for Food ProtecƟon Task Force.

Public health relevance
The State of Connecticut has achieved project milestones for the Connecticut MFRPS, and FPTF for the period of last grant. The FPTF was used as a vehicle for establishing an RRT and still reflects that orientation. This will impose a need to perhaps refocus given the RRT grant authorized last August. The Task Force has morphed into the RRT interagency advisory council. What we have achieved:  The program currently has a valid food safety inspection contract with the FDA and is continuing to meet all contract stipulations.  The State sent key personnel to all face-to-face or virtual annual meetings during the last grant cycle.  The program manager, Frank Greene serves as a board member for the MFRPS Alliance and a regional board director for AFDO.  The MFRPS Project Coordinator position has been vacant since August since the incumbent, Jenna Nicol was promoted to a Food program supervisor. She still routinely participates in initiatives that support MFRPS including conference calls via FoodSHIELD, FDA Flexible Funding Model conference calls and tactics calls regarding outbreaks.  The program participates in regular meetings with the Office of Partnerships (OP) Standards Implementation Staff as scheduled and completed during the grant period. The meetings were conducted virtually but included providing meeting space, accessibility of key State food regulatory program management and staff, and access to records, databases, and other materials supporting the assertions of MFRPS conformance.  The Connecticut MFRPS Program is in full conformance with the MFRPS Standards and despite the challenges expects to remain in conformance. Connecticut was able to reach full conformance with all the standards.